Brain glucose deficiency: mechanisms and modulation

BRAIN GLUCOSE DEFICIENCY: MECHANISMS AND MODULATION. ABSTRACT
Biochemical principles and experimental and clinical observations support the centrality of glucose metabolism
to brain function. In this context, diagnostic positron emission tomography applied to several categories of
neurological disorders such as dementia or epilepsy has long made patent reductions in glucose accumulation
in certain brain areas. However, this is not necessarily synonymous with similar reductions in downstream
metabolic flux and neural excitation. In fact, endogenous alternative fueling and hyperexcitability are often
observed in these diseases. In this proposal, we will develop the metabolic and neurophysiological means to
clarify this apparent excitability paradox by using Glucose transporter I (GLUT1) deficiency (G1D) as a model
system. The conceptual framework rests on 3 postulates applicable to an increasing number of disorders: 1)
metabolic failure results in preferential inhibitory (relative to excitatory) neuron dysfunction, which alters specific
neural circuit activities; 2) these mechanisms can be non-invasively observed at play in afflicted persons and 3)
they may be metabolically modulated for therapeutic gain. To test the postulates, we will first characterize the
interrelation between metabolism and excitability in a G1D mouse model. With this information, we will then
measure flux downstream from glucose to neurotransmitters in conjunction with neurophysiological activity in
persons. A team approach will harmonize the progression of mechanisms and results across the biological
scale spanning from molecular flux and interconversions to cells, the thalamocortical circuit, behaving mice and
the human brain. The team is indispensable because each of our investigational aims is fulfilled by more than
one of our laboratories, with the results obtained from each experimental method informing the rest of the studies.
Because the methods are inherently sensitive to flux rather than simple abundance, we will evaluate two flux
ratios that describe the overall neurophysiological and metabolic states of the G1D brain: 1) LGR (low to gamma
frequency electrical oscillation ratio) and 2) GOI (blood glucose oxidation by the brain TCA cycle index).
Translation will be achieved via a Basic Experimental Study with Humans that will test whether GOI reflects
disease severity. We will further test GOI and LGR in a Mechanistic Trial that will utilize a mechanism-testing
framework broadly applicable to metabolic interventions. The trial will investigate red blood cell exchange (i.e.,
the replacement of human G1D circulating red cells, which are deficient in GLUT1) with healthy donor cells as a
novel means to augment blood-to-brain glucose transport. The proposal benefits from structured management,
timed benchmarks and Plans for Enhancing Diverse Perspectives and Data Sharing that leverage and extend
extensive institutional and G1D Foundation resources. If successful, our approach will provide the conceptual
and methodological groundwork to transform the evaluation or treatment assessment of other thalamocortical
disorders and the mechanistic analysis of metabolic treatments in types of dementia and epilepsy.

Public health relevance
BRAIN GLUCOSE DEFICIENCY: MECHANISMS AND MODULATION. PUBLIC HEALTH RELEVANCE. Pathogenic mutations of the brain glucose transporter type I lead to glucose transporter deficiency syndrome (G1D), which is most often associated with medication-refractory epilepsy and movement dysfunction. At present, G1D is only alleviated by interventions such as the ketogenic diet, which can be poorly tolerated and afford only an incomplete restoration of neural function. A better understanding of G1D fulfills the NIH mission by uncovering new fundamental aspects of brain function while facilitating the development of new therapies aimed to restore brain metabolism and excitability.